The ECHO Measurement Core: A Framework and Resource for Assessing Environmental Exposure and Child Health

ABSTRACT
Pulmonary function in children is important to assess, as performance on this task has been associated with
higher risk of cardiovascular disease and other respiratory illnesses. High-quality assessment of objective
pulmonary function can better characterize the impact of environmental exposures in both indoor and outdoor
environments where children live, work, and play, and can be an important outcome variable for child health
development into adulthood, including children with asthma. This proposal seeks to provide a platform to
enable the ECHO components to collect and aggregate spirometry data (pulmonary tests conducted either in-
person or remotely) collected from child participants between ages 6-20 years old contracting with ZEPHRYx,
a leader in remote respiratory monitoring to 1) manage the collection and aggregation of pulmonary function
data, 2) train ECHO cohort study sites in the use of the platform, 3) provide cohort site-level dashboards to
enable easy real time continuous monitoring of participant spirometry performance , and 5) facilitate the
relationship between ZEPHRYx data flow and that of other ECHO components so that data collected can be
stored with other ECHO data elements for later analysis.

Public health relevance
PROJECT NARRATIVE Pulmonary function in children is important to assess, as performance on this task has been associated with higher risk of cardiovascular disease and other respiratory illnesses. High-quality assessment of objective pulmonary function can better characterize the impact of environmental exposures in both indoor and outdoor environments where children live, work, and play, and can be an important outcome variable for child health development into adulthood, including children with asthma. This proposal seeks to provide a platform to enable the ECHO components to collect and aggregate spirometry data (pulmonary tests conducted either in-person or remotely) collected from child participants between ages 6-20 years old.